Role of the innate immune defenses in viral infections

The introduction of potent direct acting antivirals (DAA) has significantly improved the treatment response of patients with chronic HCV infection. However, at present, these interferon (IFN)-free treatment regimens are not available for most patients worldwide, partly due to the high costs. The WHO estimates IFNα-based therapy will remain the sole available therapy particularly middle and low-income countries for the next several years. In addition, IFNα remains important for HCV genotype 3 infected patients as part of a combination therapy with DAAs. The response rate to IFN-based therapy is negatively influenced by the pre-activation state of the innate immune response, which has a genetic component. At present, it is not known whether the responsiveness to IFNα-based therapy can be improved. We therefore asked whether a rapid reduction in viremia within the first 24 hours of therapy with DAAs improves the IFN response of patients who had failed a standard course of pegylated IFN (PegIFN)/ribavirin (RBV) therapy in the past. Thirty-one HCV-infected non-responders to previous PegIFN/RBV therapy were studied for NK cell responses during subsequent successful therapy, in which DAAs were either added to PegIFN/RBV or given alone. NK cell expression of pSTAT1 and the IFN-stimulated genes STAT1 and TRAIL were assessed as a read-out for IFN-responsiveness. The 24h-virological response to therapy with PegIFN/RBV/DAAs correlated with an increase in pSTAT1 and STAT1 expression in NK cells, which was greater than during the previous unsuccessful course of PegIFN/RBV therapy. This was associated with an increase in NK cell function as measured by increased TRAIL secretion and expression of the degranulation marker CD107a that serves as a readout for cytotoxicity. Collectively, these results show that IFN-responsiveness can be improved by inhibiting HCV replication. This may provide a rationale for a brief treatment with DAAs followed by PegIFN/RBV therapy to reduce the overall treatment costs in low and middle-income countries. Improved NK cell responsiveness to IFN may also be relevant for improved immune surveillance and prevention of viral relapse.